Clinical Features and Neuropathological Basis of Sleep Wake Behavior in Alzheimer's and PSP

PROJECT SUMMARY / ABSTRACT
Sleep-wake (S/W) disturbances are a common problem in neurodegenerative diseases, and often the main
reason for institutionalization. However, there are few effective treatments for S/W disruption specific to such
diseases and grounded on their underlying causes. Evidence suggests a bidirectional link between S/W disrup-tion and brain accumulation of amyloid-β (Aβ), but we and others have found evidence that specific phosphory-lated tau (p-tau) neuropathology is also involved in S/W problems. In our current funding cycle, we discovered
that both Alzheimer's Disease (AD) and Progressive Supranuclear Palsy (PSP) involve tau accumulation, but
the patterns of their neuronal losses in S/W-regulating brainstem and hypothalamic nuclei, and also their sleep
dysregulation, diverge markedly, pointing to distinct, selective, differential vulnerability to tauopathies. Based
on multiple breakthrough findings of divergent S/W behavior profiles of AD & PSP, and novel neuropathological
methods we developed, in the proposed renewal we aim to ascertain molecular and neurotransmitter activity
changes in vulnerable S/W disruption-driving neuromodulatory subcortical systems (NSS) regions in AD and
PSP, toward guiding selection of medications that modulate NSS function.
In AD, we found that tau-related neurodegeneration of wake-promoting (W) neurons of NSS contributes
strongly to sleep problems and correlates with AD's typical pattern of sleep fragmentation and excessive day-
time sleepiness. In contrast, we found that PSP features insomnia, short sleep duration, and deficient daytime
sleep recovery, with largely intact W neurons despite presence of tau, thus implicating selective vulnerability of
NSS sleep-promoting (S) neurons. In AD, we unexpectedly found tau-related loss of lateral hypothalamic (LH)
orexin (ORX) neurons, prior to any losses in the wake-promoting locus ceruleus. We also found an early
pattern of neuroinflammatory-related gene upregulation in both locus ceruleus and lateral hypothalamic area in
AD that differs from that seen in PSP. Such disease-specific compensatory responses in S/W-regulating nuclei
have been entirely unknown and are highly relevant to potential development of targeted drugs. There is thus
urgent need to map disease-specific NSS neurobiology beyond neuronal loss or tau/Aβ presence, to enable
rational, disease-specific therapies. We hypothesize that our innovative clinicopathogical paradigm can reveal
disease-specific pathogenic mechanisms of S/W disturbances, measured by deep antemortem phenotyping of
S/W macrostructure (e.g. sleep stages) and microstructure. We will analyze and compare clinical,
neurohistopathological and molecular correlates in our ongoing cohorts of antemortem & postmortem PSP,
AD, and healthy controls (HC). Our key hypothesis is that tau deposition and later neuronal loss and pan-
network compensatory effects on NSS neuroinflammation, neurotransmitter/peptide (NT) release, and NT
receptor gene expression mediate differential changes in sleep-wake physiology: 1) in AD, predominantly via
molecular changes in wake-promoting nuclei, but 2) in PSP, via changes in NREM-promoting nuclei.

Public health relevance
PROJECT NARRATIVE This study aims to discover the causes for sleep-wake disturbances that afflict patients with Alzheimer's Disease and Progressive Supranuclear Palsy. We will determine if the pattern of disturbed sleep in these two disorders is predicted by neuropathological and molecular changes in key areas that regulate sleep and wake in both human brain bank specimens and a subsample of patients who complete sleep measures and undergo autopsy.